Genetic Regulation of Stress Responses at the Endoplasmic Reticulum

PROJECT SUMMARY
Protein quality control allows cells to respond to environmental and molecular stressors and to remove
proteins that can lead to disease or death. The Endoplasmic Reticulum (ER) is sensitive to protein misfolding
and overcrowding. ER-associated degradation (ERAD) is a defense against protein overcrowding, which can
increase cell stress. However, ERAD be balanced so that toxic proteins, with the potential to harm, are degraded,
but functional proteins are not. Using a multicellular model organism (C. elegans) we will investigate how ERAD
mechanics impact organismal level outcomes during environmental and cellular stress. Upregulation of the
ERAD complex protein, VIMP (VCP Interacting Membrane Protein, SelenoS), is an early marker associated with
ER stress, but VIMP’s precise biochemical role in facilitating ERAD is unclear. Consistent with the mission of the
National Institute of General Medical Sciences, the central objective of this proposal is to uncover how the ERAD
protein VIMP regulates stress responses at the ER. C. elegans, is a well-established model for studying ER
stress and protein homeostasis and it is amenable techniques that include fluorescence microscopy, CRISPR-
Cas modification, transgenesis, and protein biochemistry. We will use a combination these diverse technical
approaches to test the hypothesis that ceVIMP regulates gene transcription to control ER stress responses in
and between cells. The specific aims of this project are 1) to determine the cellular and subcellular sites of
ceVIMP action, 2) to define the roles of two isoforms of ceVIMP in organismal biology and stress response, and
3) to dissect ceVIMP’s participation in cell biological and biochemical pathways. We will address these aims
using complimentary genetic, biochemical, and microscopy approaches. We will establish the pattern and
requirements for ceVIMP expression, examine if differential expression of ceVIMP isoforms help animals respond
to ER stress, and identify the protein interactions that ceVIMP makes under non-stressed and stressed
conditions. Undergraduate students will participate in all aspects of this project, including experiment design,
data collection, and dissemination of results. These experiments will yield novel mechanistic insights into how
ERAD is regulated to maintain cellular and organismal health by maintaining homeostasis at the endoplasmic
reticulum. We will investigate cell-autonomous and non-autonomous interactions to complement existing
evidence that inter-tissue communication drives balanced responses to stress. Importantly, findings from these
experiments will likely be applicable to complex mammalian systems because of the high degree of genetic
conservation between C. elegans and mammals, including humans. This is particularly important because
diseases of protein misfolding and aggregation, such as cystic fibrosis and Huntington’s disease affect impact
the health of diverse cell types in ways that affect the many aspects of human physiology.

Public health relevance
Project Narrative Cells work to detect and remove stressful accumulations of non-functional proteins that can build up in the endoplasmic reticulum. The goal of this project is to find out how cells respond to stress without over- reacting, because cell death and disease can occur if cells mount much or too little of a stress response. By gaining a better understanding of how cells communicate about stress we may learn how to better treat diseases, from viral infections to cystic fibrosis.